CORE A: Administration

Project Summary (Core A)
CORE A: This core component functions as an administrative and coordinating center for all the components of
the program project. Functions include program oversight, including budget management and planning, data
processing and manuscript preparation. It will serve to facilitate interactions among the investigators in the center
as well as coordinate activities with the internal and external advisory committees. The core will function as a
centralized facility where resources can be utilized to provide support and integration of services for all
investigators. The specific aims of the administrative core are to coordinate the following activities in support the
Projects:
Aim 1: Provide grant administration and project coordination
Aim 2: Promote access to project core services, other institutional resources
Aim 3: Database management and sharing within the Project
Aim 4: Promote research training opportunities and diversity
Aim 5: Oversight and course correction to achieve overall goals
The administrative committee will make decisions regarding the use of core services. This committee is chaired
by the program director and is composed of the principal investigators of each project and the core directors. For
any adjudication, the program director will decide when there is incomplete agreement on matters that relate to
the overall program. Cost-effectiveness will be achieved through budgetary oversight by a single administrator
who communicates with program director and the project leaders. Quality control is provided as a service of the
UCSF Core Financial Unit through the internal auditing of budgets and processes. Additional quality control is
realized through the use of our internal and external advisory committees.
.